USC/UCLA Center on Biodemography and Population Health

Overview Abstract
The USC/UCLA Center on Biodemography and Population Health (CBPH) represents a unique and highly
successful collaboration between the Davis School of Gerontology of the University of Southern California
(USC) and the Multi-campus Program in Geriatric Medicine and Gerontology in the Geffen School of Medicine
at the University of California at Los Angeles (UCLA), each of which focuses exclusively on research and
teaching on aging. The CBPH has a longstanding role as a leader in efforts to promote theory-based
integration of biological measurement into population-based studies, on-going development and validation of
biological measurement protocols, and theoretically motivated research on the biological mechanisms by which
social, economic, psychological, medical and environmental factors “get under the skin” to influence the
process of health change with age. The CBPH has developed unique clinical and laboratory infrastructure and
pilot projects to improve understanding and use of biodemographic indicators, increase indicators available to
population studies, support more reliable and valid collection of data across a large number of national and
international surveys, and made advances in measurement and validation that allow population surveys to
keep pace with scientific advances in the science of aging. This application proposes a set of activities
designed to (i) expand and enhance theoretical development of the field of biodemography so that we focus on
a new generation of biomarkers reflecting molecular and cellular processes that reflect the basic mechanisms
of aging, (ii) continue efforts to attract new and promising researchers to the field, and (iii) enhance our
Center’s unique role in supporting development, validation, implementation and dissemination of new and
better biodemographic measurement protocols. The specific aims of the CBPH will be to: (1) support and
foster biodemographic research to understand the multiple and interacting factors that affect population health
(with a particular focus on expanding and deepening our understanding of the biological pathways through
which experiences and exposures over the life-course impact trajectories of health and how such influences
may vary across subgroups and settings); (2) further develop an active biodemographic research community
by engaging established and promising junior researchers in a network of scholars who can help advance
biodemographic research; (3) offer funding for pilot projects to support cutting-edge biodemographic research;
(4) support development and dissemination of new research technologies, methodologies and data through our
Research Resource & Dissemination Core and dissemination activities of Administrative Core. Such advances
are needed to support development of models of population health that provide much needed evidence for
policy planners regarding the most effective points of intervention to improve population health and reduce
health disparities. The CBPH has developed the infrastructure, resources and expertise to accomplish its
goals and continue its significant leadership role in advancing biodemographic research on aging.
OMB No. 0925-0001/0002 (Rev. 08/12 Approved Through 8/31/2015) Page Continuation Format Page

Public health relevance
Project Narrative The CBPH attempts to clarify the cellular, molecular and biological pathways through which social, economic, and psychological and experiences impact health with aging and create differential health. This is accomplished through the development of valid and reliable biological measurement appropriate for population studies, the integration of networks of experts on novel biological processes into the demographic research community, and the support of cutting edge research. Such knowledge is essential to improve our ability to improve health and reduce health disparities.